Share plus: Continuous Glucose Monitoring with Data Sharing in Older Adults with T1D and Their Care Partners

Older adults with type 1 diabetes (T1D) have an increased risk of hypoglycemia and hyperglycemia that can
result in grave health consequences, such as seizures, falls, and myocardial infarctions. Care partners (e.g.,
spouses, friends) regularly become part of the diabetes care team to assist in self-management as a person
with diabetes ages. A technological advancement that is available to people with diabetes and their care
partners to address harmful hypoglycemia and hyperglycemia is to use continuous glucose monitoring (CGM),
with a data-sharing app that allows the older adult with T1D and their care partner (dyad) to see glucose data
on their smartphones and to receive an alert before hypoglycemia or hyperglycemia occurs. Our long-term goal
is to leverage the full potential of technology and care partner interventions to optimize the support that care
partners can provide for effective glucose management in older adults with T1D. Our overall objective is to test
an intervention, called Share plus, aimed at improving the use of data sharing between persons with diabetes
and their care partners in order to maximize the benefits of CGM. The Share plus intervention provides
instruction to current CGM users about how to set up the data sharing app, dyadic communication and problem
solving, and how to establish a data-sharing action plan for older adults with T1D and their care partners.
Our central hypothesis is that Share plus will result in increased time-in-range and decreased diabetes distress
for both persons with diabetes (PWD) and their care partners (CPs) compared to the control group. The
rationale for this pilot study is that demonstrating the efficacy of Share plus will provide new opportunities for a
clinically useful approach to increase time in glucose range and decrease diabetes distress among older adults
with T1D and their care partners. The central hypothesis will be tested by pursuing three specific aims: 1)
evaluate feasibility, usability, and acceptability of the Share plus intervention compared to the control group
receiving data sharing with diabetes self-management education, 2) evaluate the effect of Share plus
intervention on time-in-range and Diabetes Distress, and 3) explore the differences between groups in PWD
and CP dyadic appraisal and coping, quality of life, diabetes self-care and care partner burden. To test our
central hypothesis, we will conduct a pilot randomized 1:1 control trial in older adults with T1D already using
CGM (N=80 dyads) in a telehealth format where the intervention group will receive data sharing and Share
plus and the control group will receive diabetes self-management education and assistance setting up the data
sharing app. The trial will include a 12-week active intervention to determine a change in primary outcomes
and a 12-week observation-only phase to determine maintenance of changes. The research proposed in this
application is innovative because it provides a needed and substantive departure from the status quo by
bringing a dyadic perspective of T1D management using data-sharing technology.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health in its focus on improving supportive behaviors of care partners of older adults with type 1 diabetes using continuous glucose monitoring with data sharing to achieve glycemic goals. The Share plus study will be a significant step in the science of data sharing and care partner interventions to prevent age-related diabetes complications. Thus, the proposed research is relevant to part of the NIH’s mission that pertains to diabetes management in the growing population of older adults with type 1 diabetes and includes integrating a wealth of research in dyadic coping and innovative diabetes technology.